IL-26 in host defense against infection by intracellular bacteria in skin

PROJECT SUMMARY/ABSTRACT
Th17 cells defend the host against extracellular bacteria by releasing cytokines that recruit and activate a
variety of other cell types, and as we discovered by the release of the antimicrobial protein IL-26 that kills
bacteria in axenic (i.e. cell-free) cultures. Although Th17 have been implicated in host defense against
intracellular bacteria, the mechanism(s) are not known. Because IL-26 is present in humans and not mice, we
investigate the role of the Th17 cytokine IL-26 in leprosy, caused by the intracellular bacterium Mycobacterium
leprae (mLEP), which provides a unique model to study human immune responses to infection. The disease
presents as a spectrum in which the clinical presentation correlates with the immune response to the
pathogen. In addition, the skin lesions of leprosy are readily accessible for study. Our preliminary data
indicates that IL-26 expression in leprosy lesions significantly correlates with lesions from patients in which
bacteria are eliminated over time. In addition, we show that IL-26 enters mLEP-infected macrophages (MΦs),
induces autophagy as well as phagolysosomal fusion, colocalizes with the intracellular bacteria and reduces its
viability. These data indicate IL-26 provides a mechanism by which Th17 cells contribute to host defense
against intracellular bacteria. Our overall hypothesis is therefore that innate activation of Th17 cells leads to
secretion of IL-26, which contributes to host defense against mLEP and other intracellular bacteria. Our
specific aims are: 1) Determine the mechanism(s) by which an extracellular antimicrobial protein, IL-26 gains
access to intracellular pathogens in MΦs, results in an antimicrobial response, 2) Discover if IL-1β, via
activation of an IL-1R+ subset of Th17 cells, represents an innate mechanism of host defense against bacterial
infection, as well as the role of monocytes/macrophages in producing IL-26; and, 3) Investigate the role of IL-
26 in host defense against intracellular bacteria residing in distinct subcellular compartments. In summary, the
proposed studies will provide new insights into the mechanisms by which IL-26 contributes to immunity against
intracellular bacteria including the role of IL-26 in skin infection.

Public health relevance
RELEVANCE TO PUBLIC HEALTH The studies in this proposal relate to a cytokine interleukin-26 which contributes to host defense against bacteria that live outside of human cells. Challenging this premise, and based on our preliminary data based on the skin disease leprosy, we propose to investigate how T cell release of interleukin-26 is relevant for host defense against bacteria that live inside human cells. It is anticipated that new insight into the immunobiology of IL-26 will lead to new therapeutic strategies to prevent and/or treat such infections.